Administrative Core

PROJECT SUMMARY
The Administrative Core is responsible for the operations, communications, regulatory and
financial oversight of the program, as well as supervision of the conduct of the proposed grant.
The program is highly integrated and the preclinical and scientific studies impact directly on
development of the translational clinical research protocols. The Administrative Core supervises
the operations of the program and facilitates reports, communication between investigators and
visits of our internal and external advisors as well as outside investigators. Clinical trials for this
PO1 are only conducted at the two lead institutions, MD Anderson Cancer Center (MDACC)
under the leadership of Dr. Elizabeth Shpall and Children's National Health System (CNHS)
under the leadership of Dr. Catherine Bollard. Pre-clinical studies will be performed at the other
three PO1 institutions in conjunction with the PO1 Project leaders including Harvard University
(Project 1-Dr. Robert Sackstein and Dr. Shpall), George Washington University (Project 2- Dr.
Douglas Nixon and Dr. Bollard) and Baylor College of Medicine (BCM) (Project 3- Dr Jordan
Orange and Dr. Katy Rezvani). The two Core A leaders, Drs. Shpall and Bollard have been
working together closely since 2004. They have developed a sustained and in depth
collaboration, which began when Dr Bollard was at BCM and was transferred seamlessly to
CNHS when she was recruited there in 2012. The core supports the Institutional Review Board
(IRB), Food and Drug Administration (FDA) Investigational New Drug (IND), Investigational
Biosafety Committee (IBC), and National Institutes of Health Office of Biotechnology Activities
Recombinant DNA Committee (NIH/OBA/RAC) submissions and reporting required for clinical
protocols in the P01. The core manages program personnel, accounts and budgets for each
section of the grant, including ongoing reports of account balances for the investigators. The
core is responsible for preparing the necessary reports to the funding agency, for the research
projects and publications. This shared resource core is an essential and critical part of this PO1.
The proposed services will facilitate the communication between the investigators and our
advisors; facilitate the translation of the pre-clinical projects to the clinic by procuring all the
requisite IND and RAC approvals in addition to providing on-going reports to the agencies, and
will provide CB units to all four projects as well as Cores C to accomplish the proposed goals
and objectives of the PO1. Centralizing these functions assures maximal efficiency, integration,
consistency and oversight, which would not be possible if each Project and Core were
individually responsible for performing the services.

Public health relevance
NARRATIVE The purpose of the Administrative component of this Core is to provide all projects with centralized support thereby assuring effective communication among all four projects and three cores. This core also arranges internal group meetings, internal/external advisory board meetings, and provides assistance to each project leader and core director with budgetary issues. This core will also be responsible for measurement of research progress and coordinating evaluation of projects to ensure productivity.